The Network for Investigation of Delirium: Unifying Scientists (NIDUS)'s 9th-13th Annual Delirium Boot Camps: A Foundation for Future Exploration

Delirium is a serious cognitive disorder associated with Alzheimer’s disease and related dementias (ADRD)
that affects ~2.6 million older adults yearly. It is a frequent complication of acute illness, surgery and, now, of
COVID-19 infection in older adults. Recognizing the relative dearth of delirium research, the National Institute
for Aging (NIA) supported the establishment of the Network for Investigation of Delirium: Unifying Scientists
(NIDUS), a collaborative interdisciplinary group of 28 investigators, from 27 institutions, to advance delirium
research and develop network infrastructure. This included the creation of an annual “NIDUS bootcamp”
conference, to bring together the growing national- and international delirium research community for
networking and education. The bootcamp aims are to advance the science of the field and to provide junior
investigators with intensive mentorship, through mock NIH application reviews, clinical and research lectures,
breakout sessions, and post-bootcamp networking. Bootcamp alumni are provided guidance on: 1) using the
NIDUS Delirium Research Hub, Measurement resources and Bibliography, 2) submitting proposals to the
NIDUS Pilot Program (13 one-year $50,000 grants awarded), NIA GEMSSTAR/CLINSTAR, the Alzheimer’s
Association, and other foundations, 3) attending Mentoring webinars, 4) participating in Junior Faculty Working
Groups, and 5) submitting research abstracts to the American Delirium Society (ADS) Annual Meeting. As PIs,
94 alumni have received 46 grants, of which 18 (40%) were NIH-funded, and published 265 original peer-
reviewed articles. NIDUS has jumpstarted the careers of many young investigators, particularly bootcamp
alumni, enabling them to launch independent programs in delirium research.
The goal of this application is to support continuation of a yearly, themed Delirium Bootcamp Conference
(DBC), to ensure that the progress of this active research community is sustained. The first-year theme will be
the inter-relationship between delirium and ADRD. The Specific Aims are to: (1) Engage and support junior
investigators in delirium research through mentorship and access to the NIDUS resources/network (2) Boost
the researchers’ funding success (3) Facilitate publication of delirium research and provide ongoing
mentorship, and (4) Facilitate networking among junior, mid-career, and senior researchers during and after
DBC. As the pool of delirium investigators expands, there is a critical need for a conference focused on
addressing cutting-edge research methods in all areas of delirium research, including the relationship with
ADRD, “-Omics” research, machine learning and big data, innovations in randomized trials, animal models and
mechanistic research, and clinical practice improvement. The DBC will provide an unparalleled opportunity to
advance cutting-edge delirium research through interactive didactic sessions and in-depth guidance on
complex and nuanced research methods essential for the highest caliber and most impactful delirium research.

Public health relevance
Delirium is a serious, yet understudied, cognitive disorder that affects millions of elder Americans, and is closely related to Alzheimer’s disease and related dementias (ADRD). The NIA-supported (2015-2020) Network for Investigation of Delirium Unifying Scientists (NIDUS), a collaborative international network of delirium investigators, developed a successful, annual “NIDUS Bootcamp” conference, laying the foundation for this proposal. The new Delirium Bootcamp (DBC) will convene junior investigators and senior faculty in an annual conference with innovations including: 1) a new thematic focus each year, with the 2021 theme highlighting ADRD; 2) focus on high-impact, state-of-the-art methodologies to advance the field in new directions; 3) finding optimal methods to address the unique challenges of delirium research, and 4) developing collaborative interdisciplinary papers to be initiated at the DBC and completed in ongoing groups; thus, fostering the training, career development and success of the next generation of delirium investigators.